Implications of Metabolic Dysfunction during Thiamine Insufficiency

Project Summary
Declining vitamin B1 (thiamine) blood levels significantly correlates with a deterioration in cognitive
function and is associated with promoting Alzheimer’s Disease (AD) neuropathology hallmarks.
Thiamine is a critical enzyme cofactor within the glycolytic metabolism network that is fundamentally
required to sustain the bioenergetic and anabolic needs of all cells. The brain’s extensive requirement
for glucose metabolism to satisfy its high energy demand makes it particularly vulnerable to TI
mediated metabolic impairment. Congruent with established AD pathology, TI produces cerebral
energy hypometabolism, inflammation, oxidative stress, and an increase in plaque formation within
the hippocampus, cortex and thalamus. Thiamine or more specifically the activated cofactor, thiamine
diphosphate (TDP) ensures the function of 3 key metabolic enzymes, PDH, α-KGDH, and TKT. A
central feature for neuronal cell injury as a result of low cellular TDP levels is severe deficits in
cerebral energy metabolism. Additionally, the activity of TKT, PDH, α-KGDH are significantly reduced
in post-mortem Alzheimer’s patients and strongly correlate with dementia rating. Yet despite progress
into the relationship between reduced thiamine levels and the neuropathology of AD, mechanistic
insight is lacking. We have established that the metabolic dysfunction as a consequence of TI
activates hypoxia inducible factor-1 alpha (HIF1α). This application will test the hypothesis that TI
mediated metabolic activation of HIF1α initiates pro-apoptotic and amyloidogenic processes that
produce the cellular and regional histological presentation of TI associated AD-neuropathology. We
plan to test our central hypothesis and, thereby, accomplish the objective of this application by (1)
Employing cell type selectivity of HIF1α KO we will reveal the contribution and relationship of
astrocytic and neuronal HIF1α activity during TI on neurological damage. (2) Using a diseased based
(3xTgAD) transgenic AD mouse model, we will establish HIF1α activation as an initiator for
amyloidogenic activity and cognitive decline as a consequence of thiamine insufficiency. (3) Utilizing
an unbiased transcriptomic analysis, we will establish the temporal impact of graded TI stress on
HIF1α transcriptional activity within neurons and astrocytes. We propose to establish the contribution
of HIF1α by using a combination of state-of-the-art methodology including RiboTag RNA-Seq and MR
Imaging coupled with cell specific Cre-drivers for HIF1α knockout and triple transgenic AD mouse
models. Establishing chronic activation of HIF1α in response to hypometabolism linked to
micronutrient deficiency would provide a significant shift discerning AD etiology and suggest possible
prophylactic strategies to limit age-related cognitive decline.

Public health relevance
Project Narrative Age related vitamin B1 (thiamine) insufficiency and subsequent hypometabolism can promote debilitating neurotoxicity and hallmarks of Alzheimer’s disease pathology. This application proposes to better understand the mechanism initiating neurological damage as a consequence of thiamine insufficiency. The proposed research is relevant to public health and the NIH’s mission, because it is expected to increase our understanding of age-related neurodegeneration from a nutritional and etiological prospective and will set the foundation for therapeutic approaches that limit progression and maintain cognitive health.